The Injectrode- An injectable, easily removable electrode as a trial lead for baroreceptor activation therapy to treat hypertension and heart failure

1 Abstract
2 Hypertension affects upwards of 25% of adults, and of those individuals with hypertension, it has been
3 estimated that between 20 to 30% are resistant to standard pharmacological treatment. Similarly, the 3-year
4 mortality rate for patients with functional Class III heart failure with reduced ejection fraction is 30%. Activation
5 of the baroreflex through electrical stimulation of the carotid sinus bulb has recently been market approved by
6 the Food and Drug Administration to treat both hypertension and heart failure by inducing large systemic
7 changes in sympathetic/parasympathetic tone. Unlike vagus nerve stimulation (VNS) which has failed multiple
8 double-blinded, randomized and sham controlled Phase III studies (RCT), stimulation of the carotid sinus bulb
9 has demonstrated large decreases in blood pressure in RCT vs sham. The failure of VNS is putatively due to
10 activation of motor nerve efferents causing therapy limiting neck muscle activation prior to engagement of
11 parasympathetic efferents to the heart or sensory afferent pathways to the Nucleus of the Solitary Tact (NTS)
12 Despite its success in clinical trials, baroreflex activation therapy (BAT) is a treatment of last resort used only
13 after drug therapies have failed.
14 There are four primary reasons driving the lack of widespread adoption of BAT: 1) the invasiveness of
15 surgical implantation is unattractive to patients with largely asymptomatic uncontrolled hypertension, 2) the
16 complexity of the present implanted system leads to multiple points of failure chronically and dramatically
17 increases the complexity of the supply chain leading to high-profile device recalls in VNS, 3) the general cost of
18 the implanted system is prohibitive, and 4) concurrent activation of the neck muscles still limits therapeutic
19 efficacy in many patients. To overcome these issues, we have developed a novel electrode called the
20 Injectrode®, a syringe injectable, flexible electrode material that conforms to complex structures like a plexus
21 or foramen once injected. We have recently shown the ability to inject on a deep nerve, connect via a simple
22 wire to an Injectrode ‘collector’ that is injected under the skin, and reliably stimulate the deep nerve using a
23 standard inexpensive non-invasive TENS unit without any wire connection spanning the skin. This system has
24 only one passive component to create a conductive conduit from just under the skin to complex neural
25 structures like the plexus formed by the carotid sinus nerve at the internal carotid artery/bulb, greatly reducing
26 the number of chronic failure points leading to adverse events.
27 In this Phase I SBIR, we will optimize and validate and refine the Injectrode concept for less invasive,
28 more robust, and more isolated BAT.
29

Public health relevance
Narrative In this study, we propose to develop a novel syringe-injectable electrode concept that can be easily removed to stimulate the plexus formed by the carotid sinus nerve into the internal carotid artery. This interface will uniquely isolate the baroreflex from off-target nerve pathways as a minimally invasive treatment for hypertension and heart failure. We will perform benchtop characterization, and perform animal testing in appropriately sized acute and chronic animal models to refine the efficiency of energy transfer, while optimizing the injection surgical procedure for the carotid plexus.